Investigate the mechanism lamins regulate genome organization and gene expression during development

Abstract
Lamins are type V intermediate filament nuclear proteins. Lamins assemble into
a filamentous network and is the major structural element of the proteinaceous
meshwork called the nuclear lamina located underneath the inner nuclear envelope.
The chromatin regions interacting with this meshwork is called the nuclear Lamina
Associated Domains (LADs). Studies using tissue culture cells in vitro show that the
lamins maintain genome and nuclear integrity. Since mutations in the lamin genes
cause a large number of human diseases, it is important to understand the basic
functions of lamins in vivo. This proposal aims to determine the mechanism by which
lamins regulate 3D genome organization and gene expression during development.
The experimental plan builds upon a number of advances made in the last
several years. By studying mouse embryonic stem cells (mESCs), a chromatin model,
referred to as Histone Lamina Landscapes (HiLands), was developed to classify
different types of chromatin based on histone binding, epigenetic modification, and
LADs. Aided by this classification, it becomes clear that lamins differentially regulate two
distinct LADs defined as HiLands-B and -P in mESCs. Further coupling of the LADs
studies with Hi-C analyses, it is possible to discover that the HiLands-B LADs are
detached from the nuclear lamina, while HiLands-P LADs are decondensed at the
nuclear periphery. These LADs defects result in changes in global 3D chromatin
interactions and gene expression in the lamin null mESCs. To enable the study of how
lamins regulate development, several methods are developed to allow high quality
mapping of LADs, Hi-C, and epigenome in a small number of cells isolated from
embryonic tissues. Additionally, careful characterization of lamin deletions during mouse
development points to two embryonic cell types, the embryonic cardiomyocytes and
extraembryonic endoderm cells (EXE cells), as great models to investigate the
mechanism by which lamins regulate genome organization. Importantly, these two cell
types have classical (cardiomyocytes) or inverted (EXE cells) genome organization.
Thus the proposed study will enable the investigate into whether and how lamins use
similar or different means to regulate two distinct genome configurations during
development.

Public health relevance
Project Narrative The major goal of this research project is to determine the roles of the nuclear lamin proteins in organizing and regulating the genome during development. The lamins are major architectural proteins of the nucleus of mammalian nucleus where they are involved in the regulation of many nuclear processes. Interest in the study of lamins has increased greatly in recent years due to the large number of mutations in lamin genes causing many diseases ranging from premature aging to cardiomyopathies and muscular dystrophies. The studies proposed in this grant will use a combination of genomic and CRISPR-Cas9 techniques to determine how lamins regulate the genome during development, which will aid the understanding how mutations in these lamins could contribute to human diseases.